Administrative Core

ABSTRACT
The Administrative Core (Admin Core) supports all aspects of the U54 Partnership for the Advancement of
Cancer Research between New Mexico State University and Fred Hutchinson Cancer Center. The
Partnership’s cancer research, research education, and outreach activities are made possible through efficient
program leadership by Dr. Graciela Unguez at NMSU and Dr. Julian Simon at Fred Hutch. Working jointly, Drs.
Unguez and Simon have assembled an Admin Core staff including Program Managers (Ms. Lené Löest at
NMSU and Ms. Marilyn Drennan at Fred Hutch) with extensive experience managing the Partnership’s
budgets, communications, and logistics. The Admin Core benefits from close ties with institutional leadership
on both campuses.
Partnership programs are administered collaboratively, and, when feasible, in both locations. The 1,653 mile
separation between the two campuses has necessitated effective long-distance communication since long
before the COVID-19 pandemic. Over the Partnership’s 20-year history, the Admin Core has successfully
launched and optimized research, education and outreach programs in New Mexico and Washington State
through committed effort to long distance coordination, management, and communication. While the pandemic
has impacted in-person activities, the Partnership was able to adapt and redeploy resources to advance
programmatic goals.
The Admin Core has effectively managed allocation of resources, logistical support for in-person and remote
program meetings as well as oversight of planning and evaluation of research, education and outreach efforts
while consistently maintaining a high level of productivity, effectiveness and impact. The Admin Core’s support
of Partnership activities has enabled progress toward meeting the goal of advancing health equity.
Development of the Guiding Principles elaborated in Overall, is a major commitment to meeting that goal.